RI-INBRE CELs Equipment Request

Program Director/Principal Investigator (Last, First, Middle): Cho, Bongsup P. PROJECT SUMMARY We request an administrative supplement to purchase instruments at two RI-INBRE Centralized Research Core Facilities (CRCF) Extension Laboratories (CELs). Specifically, we propose to replace a broken flow cytometer at Roger Williams University (RWU) with a new benchtop flow cytometer. We also propose to purchase an automated fluorescence microscope at Providence College (PC) to enhance access to this technology. Both instruments would be accessible to RI- INBRE and RI investigators. Funding this administrative supplement to purchase these two instruments for inclusion into these RI-INBRE CELs will preserve and enhance the benefit of these instruments by ensuring they are accessible to RI-INBRE researchers through being part of the CRCF. By being included in the CRCF instrument listings, the maximum exposure of these instruments to the RI-IBRE and RI biomedical community is possible. PHS 398 (Rev. 03/2020 Approved Through 02/28/2023) OMB No. 0925-0001 Page

Public health relevance
Program Director/Principal Investigator (Last, First, Middle): Cho, Bongsup P. Project Narrative The funding of this Equipment Supplement application will allow RI-INBRE’s Centralized Research Core Facility to replace a broken flow cytometer and add microscopy resources through extension laboratories at two different RI-INBRE partner institutions. These instruments will support numerous grant-supported research programs and be used to train undergraduates in biomedical science. OMB No. 0925-0001/0002 (Rev. 03/2020 Approved Through 02/28/2023) Page Continuation Format Page